REPOSITORY AND DISTRIBUTION CENTER FOR REAGENTS

Biotech Research Laboratories, Inc. proposes to provide supportive services in storage, catalog, distribution and record keeping for research reagents. Specifically, Biotech will be prepared to perform the following: 1. Provide a shipping and receiving facility for the distribution of reagents. a. Receive NIH request forms (381-2); b. Ship requested reagent by best available method; c. Receive worldwide shipments. 2. Provide inventory control of reagents. a. Record shipments; b. Provide quarterly report of materials distributed and received, equipment condition, and revenues received; C. Physical inventory of repository annually. 3. Provide storage facilities. a. Provide 3,000 square feet of repository space; b. Provide adequate electrical service; c. Provide emergency generator service; d. Maintain room temperature of 72 + 4; e. Provide central alarm service; f. Provide LN2 with tank. Biotech intends to provide safe, secure, and appropriate temperatured storage space for the NIAID repository and provide timely deliveries of research reagents.